Mechanisms of Silent Synapse Maturation for Excitatory Network Refinement

Abstract
Silent synapses are instrumental in experience-dependent cortical network reorganization. This process is
particularly prevalent during developmental critical periods when silent synapses are abundant. Genesis, loss,
and maturation of these silent synapses alters the synaptic connection pattern to establish the fundamental
processing architectures of excitatory neural networks during critical periods. Whether silent synapses mature
or are lost is a critical decision point to determine the fate of synaptic connections between neurons. Thus, the
delicate balance of the pace of silent synapse maturation and their loss determines the outcome of the refinement
process during critical periods. However, the molecular underpinnings regulating the pace of silent synapse
maturation and how changes in pace impact local neural circuits and sensory perception remains elusive. Our
previous studies report that the pace is controlled by the opposing but cooperative function of two postsynaptic
signaling scaffolds, PSD-93 and -95, that inhibits and promotes silent synapse maturation, respectively. Using
unbiased quantitative phosphoproteomic approaches, we identified signaling pathways affected by PSD-93 and
-95 that govern the maturation. The proposed experiments employ genetic manipulations using viral vectors and
transgenic mouse models, combined with electrophysiological analysis, quantitative proteomic analyses, and
confocal imaging to focus on a fundamentally new concept of silent-synapse based mechanism driving
experience-dependent cortical development. Results will reveal a so far unknown signaling mechanism in
regulating the pace of silent synapse maturation. Expected results will advance our understanding of the
molecular mechanisms of neural network refinement, and their impact on local circuits and visual perception,
exemplified in the primary visual cortex, but relevant to cortical networks in general.

Public health relevance
Narrative Experience-dependent neural network refinement is a fundamental process during postnatal brain development. This project is to investigate the molecular mechanisms that underlies silent synapse-based cortical excitatory network refinement. Specifically, we aim to dissect a signaling hub, coordinated by the signaling scaffold PSD- 95 that controls the pace of silent synapse maturation local visual cortex circuits and visual perception.